Disease modifying therapies, serum neurofilament light chain levels, and multiple sclerosis outcomes in Black and Hispanic persons

PROJECT SUMMARY/ABSTRACT
Why Black or Hispanic people residing in the US have higher multiple sclerosis (MS)-related disability at
younger ages than White people is vastly under-studied. The proposed research will be the first to determine
how type and timing of immunomodulatory disease modifying therapies (DMTs) use and/or neuroaxonal injury
at MS diagnosis vary by race or ethnicity and how such differences contribute to disparities in long-term
prognosis. Recent studies in White persons with relapsing MS (pwRMS) have shown that initiation of highly
efficacious DMTs (HETs), but not modestly efficacious DMTs, within 5 years of symptom onset are associated
with a reduction in clinically meaningful disability. We hypothesize that the failure to prescribe HETs early in the
disease course are primarily responsible for racial and ethnic disparities in MS outcomes. Early initiation of
HETs may be particularly important in the subgroup of patients with high levels of serum neurofilament light
chain (sNfL, a marker of greater neuroaxonal damage) at diagnosis. High sNfL levels are associated with
faster disability progression in White pwRMS–but only when HETs are withheld. If a higher proportion of Black
and Hispanic pwMS have high sNfL levels compared with White pwRMS, this could also help explain
disparities in MS outcomes–but this has not been studied. The overarching goal of this proposal is to
determine whether the failure to prescribe HETs, particularly in the subgroup of patients with greater
neuroaxonal damage at diagnosis, is responsible for worse outcomes in Black and Hispanic pwRMS. We will
address these goals by conducting: 1) a retrospective cohort study of 2300 newly diagnosed pwRMS including
450 Black and 600 Hispanic individuals identified from the population-based membership of Kaiser
Permanente Southern California (KPSC); and 2) a prospective cohort study of the MS Sunshine participants
(R01NS075308, PI Dr. Langer-Gould), which includes stored sera samples obtained at MS diagnosis between
2011 and 2014 from 123 Black, 192 Hispanic and 249 White KPSC members. The specific aims of this project
are: 1) To determine whether lack of HET use early in the disease course mediates the relationship between
race/ethnicity and disability in individuals with newly diagnosed relapsing MS; 2) to determine whether Black or
Hispanic pwMS have greater neuroaxonal damage early in the disease course; and 3) to examine whether the
lack of HET use in pwRMS with greater neuroaxonal damage early in the disease course is associated with a
worse prognosis. Other existing cohorts cannot address these questions because they include predominantly
White pwMS. Completion of these aims will: (1) improve our understanding of how inequities in DMT use
contribute to worse outcomes in pwRMS; (2) strengthen the evidence for a relationship between early
neuroaxonal damage and worse MS prognosis; and (3) help guide targeted interventions to prevent MS-
related disability by identifying high-risk subgroups. The results of this study have the potential to guide
global MS treatment policies and alleviate racial and ethnic disparities in MS outcomes.

Public health relevance
PROJECT NARRATIVE Why Black or Hispanic persons residing in the US have higher multiple sclerosis (MS)-related disability at younger ages than White persons is vastly understudied. We will leverage a large, multi-ethnic population of newly diagnosed persons with MS with 10-15 years of follow-up to determine whether this is because Black and Hispanic persons with MS: 1) are less likely to receive highly efficacious treatments; 2) have more neuroaxonal damage at disease onset; or 3) a combination of both, compared to White persons with MS. The results of the proposed study have the potential to alleviate racial and ethnic disparities in MS outcomes.